Assembly and Dynamics of Molecular Machines in Genome Maintenance

ABSTRACT
To maintain stable genomes, cells carry out an accurate and timely replication program and repair such
deleterious DNA lesions as double-stranded breaks, inter-strand crosslinks, and damaged replication forks.
Project 1 of the parent NIH R35GM131704 MIRA grant (PI: Spies) investigates the molecular machinery of
homologous recombination (HR), a cellular process that provides the most accurate means to repair of these
deleterious DNA lesions and damaged replication forks, and thereby contributes to genome stability in normal
cells, but also helps cancerous cells to develop resistance to radiation and DNA-damaging chemotherapy. We
are building a quantitative description of the central step in HR and its regulation, which will draw on the
importance of protein plasticity and conformational dynamics in molecular recognition.
Project 1 under this MIRA award utilizes single-molecule total internal reflection fluorescence microscopy
(smTIRFM), correlated optical tweezers and fluorescence microscopy (CTFM), mass photometry and
biochemical reconstitutions to visualize and quantify the dynamic assembly and remodeling of the nucleoprotein
complexes coordinating HR and processing of alternative DNA structures. The key intermediate in all processes
we study under this project is a dynamic complex between ssDNA binding protein RPA (Replication Protein A),
RAD51 recombinase and DNA. In HR and in protection of stalled and damaged DNA replication forks, RPA and
RAD51 compete for the ssDNA binding and this competition is tightly regulated.
As a summer student, Ms. Sabryn Labenz (University of Northern Iowa) will utilize mass photometry to collect
data on the oligomeric state distribution of the wild type RAD51 recombinase, as well as RAD51 mutants that
have altered protomer-protomer interaction interface. The ability of RAD51 to form oligomers of different sizes
will be correlated with the rate of the RAD51 nucleoprotein filament formation (determined by CTMF) and the
ability of RAD51 to displace the ssDNA binding protein RPA and carry out the DNA strand exchange reactions.
The enumeration of the RAD51 oligomeric states and quantification of the nucleoprotein formation will enable
Sabryn to improve the theoretical model for the RAD51/RPA competition.

Public health relevance
PROJECT NARRATIVE Homologous genetic recombination plays key role in maintenance of genomic stability in normal cells, but assist cancerous cell in uncontrolled proliferation and developing resistance to DNA damaging chemotherapeutics. Mechanistic understanding of the fundamental molecular mechanisms underlying homologous recombination will help us to understand how best to target this enigmatic protein in cancers.